Role of Lateral Hypothalamic Neurotensin Neurons in Energy Balance

PROJECT SUMMARY
Obesity and chronic pain frequently occur together, which is exacerbated by current pain medications that induce
further weight gain. Our limited understanding of the common neurobiological factor(s) underlying obesity and
pain is a major knowledge gap preventing design of effective treatment strategies. The neuropeptide Neurotensin
(Nts) acts centrally to promote analgesia and weight loss, hence, augmenting Nts signaling could combat
comorbid obesity and chronic pain. Yet, the endogenous source of Nts and the signaling mechanisms mediating
these effects remained elusive. Over the last funding periods we began to address this knowledge gap by
characterizing an endogenous source of Nts that mediates weight loss: Nts-expressing neurons in the lateral
hypothalamic area (LHANts neurons). We’ve published that activating LHANts neurons in normal weight mice
reduces feeding and body weight via an Nts-dependent mechanism. Our new data show that activating LHANts
neurons also alleviates pain. The next challenge is understanding how LHANts neurons elicit these effects to
leverage them for treating obesity-pain. This is important because activating all LHANts neurons in normal weight
mice reduces weight but fails to do in obese mice. Our studies will explain why the anorectic effect is lost in the
obese state and how we can reinstate it. Our pilot data suggest that obesity disrupts Nts expression, which may
impair its suppression of feeding/pain. However, our data support that this may be overcome in obese mice by
activating LHANts input to the ventral tegmental area (VTA) or the NtsR-expressing neurons there, which can
restore anorectic and analgesic effects. We therefore hypothesize that obesity reduces endogenous Nts
signaling via the LHANtsVTA pathway, but augmenting this pathway can reduce feeding, weight, and
pain in obese mice via Nts-NtsR signaling. Aim 1 defines how expression of Nts, its receptors, and Nts release
to the VTA is altered in obesity. Aim 2 combines dual recombinase mice and optogenetics to establish how
augmenting the LHANts neuronal input to the VTA restrains feeding and to identify which Nts Receptor isoform
mediates these effects. Aim 3 uses the same approach to reveal how LHANts neuronal input to the VTA alleviates
pain in obese mice. Our basic neuroscience studies will provide rationale for leveraging the central Nts system
to support weight loss and pain relief, and mechanistic evidence for identifying the best cell/receptor target.
Ultimately, this knowledge has potential to recognize Nts as a common actionable target for both obesity and
pain and could guide development of Nts-based strategies to safely treat and alleviate the suffering of the millions
of Americans with obesity-induced pain.

Public health relevance
PROJECT NARRATIVE This project is expected to broadly impact the massive public health problems of obesity and chronic pain. This research will identify neurotensin circuits that act via the ventral tegmental area of the brain to modulate feeding behaviors and the perception of pain. The identified endogenous analgesic mechanism may be leveraged to treat comorbid obesity and pain safely and simultaneously.